Analytical Tools for Light-Initiated Zn2+ Signaling in Neurodegenerative Disease

PROJECT SUMMARY
Overwhelming evidence has implicated oxidative stress and zinc dysregulation as mechanisms that underlie
neurodegeneration, especially in Alzheimer’s disease (AD) and Parkinson’s disease (PD). In its free, ionic state,
Zn2+ undergoes co-release with glutamate in selected brain regions and interacts with conserved binding sites
on regulatory proteins, such as transporters, receptors, and intracellular signaling proteins. These interactions
directly influence the release and uptake of multiple neurotransmitters, including dopamine (DA), a
catecholamine that plays important roles in learning and memory. However, chemical modification of amino acid
residues, including those involved in Zn2+ binding, occur in AD and PD due to formation of reactive oxygen
species (ROS). These modifications hamper Zn2+’s ability to modulate the function of proteins that control the
release and uptake of DA and other signaling molecules. The resulting imbalances in neurotransmitter levels
can impair neuronal function, compromise neuronal health, and impede cognitive processes. Unfortunately,
studies of how Zn2+ release and ROS production interact to regulate sub-s neurotransmitter signaling have been
neglected because the analytical methodology is underdeveloped, resulting in knowledge gaps that hinder the
development of therapeutic strategies aimed at normalizing metal signaling. Thus, there is a critical need to
identify and quantify these functional and structural changes in neurodegenerative disease. Our overarching
goal is to develop analytical approaches to determine how Zn2+’s ability to modulate DA release and uptake on
the sub-s timescale is affected in AD and PD. Our central hypothesis is that oxidative modification of histidine
residues at binding sites impede Zn2+’s regulatory function and is a common mechanism in AD and PD model
organisms. We have previously combined fast-scan cyclic voltammetry (FSCV) with light-induced release of Zn2+
from custom-designed, photoreactive cages, and showed that treatment of zebrafish with rotenone impeded the
inhibitory effect of Zn2+ over DA uptake, yet potentiated this effect over release. We will further develop our
FSCV/photorelease technique to determine how disease state alters Zn2+ signaling in genetic models of AD and
PD. Targeted proteomic analyses of brains will then identify sites of oxidative modifications on specific amino
acids involved in Zn2+ binding. Our specific aims, which are complementary, yet independent, are: 1) Determine
how extracellular Zn2+ transients affect DA release and uptake with sub-s and micron-scale precision, 2)
Determine how alterations in intracellular Zn2+ levels influence DA release/uptake and ROS generation, and 3)
Correlate specific protein amino acid modifications with functional alterations of Zn2+ on DA release/uptake.
Importantly, our approach is adaptable to measuring how other biologically active metals, such as Fe3+, Cu2+,
and Mn2+, affect other electroactive signaling molecules, such as norepinephrine and histamine, with high
spatiotemporal resolution. Thus, there is the promise that researchers can identify specific metal-binding sites
that have been modified in AD, PD, and other diseases, and design selective drug therapies to target them.

Public health relevance
PROJECT NARRATIVE Free metals play important roles in brain function and disease. This proposed research will generate tools that we will use to understand how metals and neurotransmitters interact in living brains, using zebrafish as a model organism. Application of these tools to Alzheimer’s disease and Parkinson’s disease will enable us to understand the underlying causes of dopamine neuron dysfunction in both disorders.